Improving Mental Health Outcomes for Fetal Alcohol Spectrum Disorder: Tailoring Dialectical Behavior Therapy for Adolescents in a Community Mental Health Clinic

PROJECT SUMMARY/ABSTRACT
Fetal alcohol spectrum disorders (FASD) are a highly prevalent neurodevelopmental disability yet extremely
underserved by systems of care. FASD is linked to varying abilities in areas of executive function, attention, memory,
adaptive skills, and emotion regulation. These emotion regulation difficulties are associated with 90% of individuals with
FASD having co-occurring mental health disorders. However, no evidence-based mental health treatments have been
adapted or tested for this population. This gap is particularly salient for the adolescent period, as many of these co-
occurring disorders arise during this developmental timeframe.
Dialectical behavior therapy for adolescents (DBT-A) is an evidence-based cognitive-behavioral therapy that
specifically targets the biological predisposition for emotion dysregulation and invalidating environments that adolescents
with FASD commonly experience. DBT-A is an intensive treatment program, involving weekly skills groups with
adolescents and their caregivers, weekly individual therapy for adolescents, and 24/7 phone coaching. The proposed
project aims to adapt DBT-A for adolescents with FASD and their caregivers and test the feasibility of the adaptations in a
community mental health clinic. Given low FASD awareness among community clinicians, this project will also involve
the development of trainings for mental health clinicians on FASD. Implementation science, specifically the EPIS
framework (Exploration, Preparation, Implementation, Sustainment) and attention to social determinants of health will
guide the conduct of the project. Input from a community advisory board consisting of adolescents with FASD, caregivers,
and mental health clinicians will be prioritized at every step of the EPIS process.
The aims of the proposed project are as follows: Aim 1- Systematically develop materials for FASD-informed
DBT-A administration utilizing the EPIS implementation framework; Aim 2 - Conduct a feasibility trial of DBT-A with
adolescents with FASD and their primary caregiver. The proposed project is an essential foundational step to address the
gap in mental health care for individuals with FASD, as well as assist mental health clinicians in best serving this
population. The feasibility of this project is supported by emerging research adapting DBT to other populations with
neurodevelopmental difficulties. As this project will take place in an existing clinic in the community, it allows for careful
examination of implementation factors that could support future generalizability to other existing mental health clinics.
Additionally, the proposed project will provide mentored training to prepare the PI for a career as an independent
researcher. Through the support and guidance of experts in the fields of FASD, intervention, implementation science,
DBT, and social determinants of health, the PI will gain essential competencies in mental health intervention
development, rigorous implementation and dissemination processes, and community-member engagement.

Public health relevance
PROJECT NARRATIVE Fetal alcohol spectrum disorders (FASD) affect 2-5% of the school-aged population, with up to 90% of individuals meeting criteria for a co-occurring mental health disorder. Yet, not a single mental health intervention has been developed for this population. The current project will adapt Dialectical Behavior Therapy for Adolescents (DBT-A) for individuals with FASD and conduct a feasibility trial of these adaptations in a community mental health clinic utilizing an implementation science framework.